HER2 PET imaging to assess HER2 heterogeneity and predict response to HER2-targeted ADC therapy in urothelial carcinoma

PROJECT ABSTRACT
The management of metastatic bladder/upper tract (urothelial) cancer has been transformed over the past five
years, with FDA approval of anti-PD-1/PD-L1 antibodies, an FGFR-selective kinase inhibitor, and most recently
two antibody-drug conjugates (ADCs). Despite these advances, most patients with metastatic urothelial cancer
still die from their disease. The HER2 receptor tyrosine kinase (encoded by the ERBB2 gene) is implicated in
the pathogenesis of several cancer types, and drugs that target HER2 have an established role in the
management of breast, lung, and esophagogastric cancers. While HER2 mutations and/or amplification are
present in approximately 20% of metastatic urothelial cancers, older HER2-targeted antibodies and kinase
inhibitors had only modest clinical activity in urothelial cancer. Unprecedented clinical activity was recently
demonstrated with a new generation of HER2-directed ADCs in breast and lung cancers resistant to older HER2-
targeted therapies, including HER2-low breast cancer and ERBB2-mutated lung cancer. The current proposal is
based on 1) preliminary data indicating frequent mutational discordance of ERBB2 in paired primary and
metastatic tumors collected from individual patients with urothelial cancer; and 2) durable responses to second-
generation HER2-directed ADCs in a subset of patients with HER2-expressingurothelial cancer. We hypothesize
that pre-existing HER2 expression heterogeneity will be a common mechanism of resistance to HER2-targeted
ADCs in urothelial cancer and that molecular imaging can identify those patients most likely to achieve durable
responses. To test this hypothesis, we will leverage a largest-of-its-kind prospective molecular characterization
effort and a novel molecular imaging platform (89Zr-ss-pertuzumab PET) to define the prevalence of HER2
expression heterogeneity in urothelial cancer, its association with ERBB2 mutational status, and its impact on
HER2-targeted ADC response. We will accomplish these translational objectives through three broad
approaches: 1) We will perform molecular analyses of paired primary and metastatic tumors collected from
patients with urothelial cancer; 2) We will explore the extent of lesion-to-lesion HER2 heterogeneity in metastatic
urothelial cancer using a bespoke HER2 PET imaging platform (89Zr-ss-pertuzumab PET); and 3) We will use
89Zr-ss-pertuzumab PET and tumors collected before treatment and at the time of disease progression on HER2-
targeted ADCs to study the impact of HER2 heterogeneity on the durability of response to this novel drug class.
Mechanisms of HER2 ADC resistance will be functionally explored using patient-derived urothelial cancer
organoid and xenograft models. Given the promising clinical activity of HER2-directed ADCs in patients with
urothelial cancer, we predict that the studies proposed will directly influence the design of future clinical trials of
HER2-targeted therapies for patients and establish the clinical utility of HER2 PET as a predictive biomarker of
response in patients with urothelial cancer being considered for HER2-targeted therapy.

Public health relevance
PROJECT NARRATIVE This project will leverage our institutional experience in tumor profiling and molecular imaging to study the clinical significance of molecular heterogeneity in urothelial cancer, with a focus on the HER2 receptor tyrosine kinase. As a complement to tumor analyses, HER2 PET imaging will be used to study lesion-to-lesion differences in HER2 expression and to determine if patients with heterogeneous HER2 expression are less likely to benefit from treatment with HER2-targeted antibody-drug conjugates (ADCs). Given the promising clinical activity of HER2-targeted ADCs in patients with urothelial cancer, we predict that the studies proposed will accelerate the clinical development of HER2-targeted ADCs and establish a clinical role for HER2 PET imaging as a guide to patient selection. .